Mechanisms of BET bromodomain metabolic reprogramming in triple negative breast cancer

In triple negative breast cancer (TNBC), a tumor type that may be amenable to immune-based treatment, the
biology of malignant cells in metastases drives mortality, rather than the biology of primary tumors. The
realization that only about a fifth of patients really respond to immunotherapies suggests that more effort
should be dedicated to understanding basic mechanism in the tumor microenvironment. Metabolic programs in
both primary tumor and distant metastasis affect responsiveness to immunotherapy, but many important
molecular switches of metabolism remain unexplored. The BET bromodomain proteins, comprising BRD2,
BRD3 and BRD4 in somatic cells, are new critical regulators of metabolism and could be important targets in
immunotherapy for TNBC. These transcriptional co-regulators are well known players in tumor cell prolifer-
ation, but are only recently identified as critical for metabolism and metastasis. As we show here, individual
BET proteins also control PD-L1 expression, central to immunotherapy. Small molecule pan-BET inhibitors
(BETi), such as JQ1, show promise in several pre-clinical cancer models. Manipulation of individual BET
proteins also increases fatty acid oxidation by transcriptional upregulation of metabolic genes and transacti-
vates PPARγ target genes like PGC-1α, in ways that drive TNBC metastasis. Metabolic reprogramming is of
interest, and Type 2 diabetes is a useful place to start. These mechanisms are critically important in
metabolism of the TNBC microenvironment. Our preliminary data show that BRD2 and BRD4 oppose each
other in metabolic functions: BRD2 co-represses PPARγ target genes and OXPHOS gene transcription, but
BRD4 opposes glycolytic metabolism in TNBC. This suggests that properly selective BET inhibition could
improve efficacy of immunotherapies. Our long term goal is to understand how BET bromodomain proteins
reprogram metabolism to regulate progression and metastasis in TNBC, and immunotherapy responses. The
objective here is to resolve the individual functions of each BET family member with selective knockdown and
next-generation BETi, to define gene networks that regulate metabolism, metastasis and checkpoint function.
The central hypothesis is that BET proteins control a metabolic switch in TNBC metabolism that is critical for
metastasis, and can be reprogrammed for immunotherapy benefit. Strong preliminary data support three
Specific Aims: 1. Determine how BET proteins control metabolic plasticity to drive progression of TNBC. 2.
Determine how BET proteins regulate breast tumor immune escape through the PD-1/PD-L1 axis. 3.
Determine how BET protein-regulated metabolic plasticity facilitates anti-PD-1/PD-L1 strategies. We will
undertake an observational study of TNBC patients with and without Type 2 diabetes and metformin treatment.
We expect to find that a BET protein metabolic switch regulates progression and metastases in TNBC,
coupling metabolic reprogramming to checkpoint function. These insights will help tailor next generation BETi
to maximize therapeutic efficacy of immunotherapy combinations and minimize metastasis risk in TNBC.

Public health relevance
NARRATIVE Triple-negative breast cancer is an aggressive subtype and difficult to treat, because such patients do not respond to hormone therapy and show worse outcomes after conventional chemotherapy. A lack of identified `druggable' molecular targets limits the development of targeted therapeutic strategies; however, a metabolic approach based on BET bromodomain signaling to reprogram immune checkpoints reveals promising new opportunities. This study is expected to have major public health impact because we develop innovative tools to meet the challenge of how metabolic switches can be leveraged to improve immunotherapy for this subtype.